IRACDA at Rutgers: INSPIRE Postdoctoral Training Program

SUMMARY/ABSTRACT
This application seeks to renew the IRACDA at Rutgers - INSPIRE Postdoctoral Training
Program- that began at Robert Wood Johnson Medical School (RWJMS) in August of 2010.
RWJMS is now part of Rutgers University, expanding the pool of postdoctoral fellows and
laboratories. INSPIRE would like to continue working towards its two goals: (1) to train the next
generation of scientist-educators by creating an innovative postdoctoral training model and (2) to
encourage undergraduates underrepresented in research to consider careers in biomedical
sciences. The success of INSPIRE is evident in that (1) 74% of INSPIRE Fellows have obtained
academic positions after research training at Rutgers laboratories and mentored teaching at our
partner institutions, Medgar Evers College – CUNY, New Jersey City University, NJ and William
Paterson University, NJ, three institutions that educate students underrepresented in biomedical
research; and (2) INSPIRE has promoted improved and new science courses, Scientific Teaching
training by partner school faculty, and increased research experiences for the undergraduates at
partner schools. To increase the impact of INSPIRE the program will add a 4th year of formal
training for the Fellows, and will expand mentoring programs for the partner school students.
The proposed INSPIRE IRACDA program will include 3 years of funded postdoctoral training
program for 5 trainees per year, with a 4th year of training to be supported by the Rutgers
Research Mentors. Some INSPIRE Fellows will be recruited to become Rutgers faculty, as
Rutgers Presidential Postdoctoral Fellows, a program to build Rutgers faculty diversity. Trainees
will participate in mentored research in Rutgers laboratories; a structured career development
program; a structured educational component including intensive training in scientific teaching
during year 1; and mentored teaching and course development at partner schools during years 2
and 3, and focused training in academic writing in year 4. The program will promote research
and teaching interactions between partner school students and faculty with faculty and
postdoctoral trainees at a research-intensive university. Program evaluation will measure (a)
undergraduate student application and entry into research programs and awareness of research
careers; (b) curriculum development at partner schools of 4 science courses to increase student
engagement in STEM courses; (c) research collaborations between Rutgers and its partner
schools facilitated by ongoing summer research by partner school undergraduates at Rutgers,
supervised by the Fellows and (d) entry of 70% of INSPIRE postdocs, including underrepresented
trainees, into education/research careers, including becoming Rutgers research faculty.

Public health relevance
Project Narrative The renewal of the IRACDA at Rutgers – INSPIRE Postdoctoral Training Program - will support the training opportunities for INSPIRE Fellows, postdoctoral fellows who will be prepared to excel as the next generation of scientist-educators. INSPIRE postdoctoral training in research and education will be provided at Rutgers University, a public institution that trains over 700 postdoctoral fellows each year. Finally and most importantly, this Training Program will support the education and research environment at three public institutions, Medgar Evers College – CUNY, New Jersey City University, NJ, and William Paterson University, NJ, that have a demonstrated commitment to educating undergraduate students from groups underrepresented in biomedical research careers.